Systematic Implementation of Patient-centered Care for Alcohol Use Trial: Beyond Referral to Treatment

SUMMARY. About 14% of US adults have an active alcohol use disorder (AUD) and most never receive
treatment. Experts agree primary care should play a major role in identifying AUD and engaging patients in
treatment. However, screening, brief intervention and referral to treatment (SBIRT) alone has not been found
to increase AUD treatment. High-quality patient-centered primary care usually relies on shared decision-
making, which can help motivate patients and support them in finding treatments that are aligned with their
preferences. While patients likely prefer shared decision-making with their primary care providers, time
pressures and other barriers in primary care may limit the reach of shared decision-making in primary care;
centralized approaches with systematic outreach could decrease the burden on primary care and have greater
reach, but it is unknown whether shared decision-making for AUD will be effective in the absence of an
established clinical relationship. SPECIFIC AIMS: The Systematic Implementation of Patient-centered Care for
Alcohol Use Trial is a pragmatic, cluster-randomized, effectiveness-implementation trial testing two
interventions to systematically implement shared decision-making with primary care patients with AUD: a
primary care intervention and a centralized intervention. The specific aims of the trial are to test whether each
intervention—compared to usual care alone—(1) increases the proportion of primary care patients engaged in
AUD treatment over a year follow-up or (2) decreases alcohol use over 2 years follow-up. METHODS: The
proposed trial is conducted in 30 primary care clinics in which usual care includes SBIRT. The trial randomizes
the 30 clinics to one of three approaches to managing AUD: (1) usual care; (2) a primary care intervention
added to usual care that uses state-of-the-art implementation interventions to systematically encourage
primary care providers to offer routine shared decision-making for AUD; and (3) a centralized intervention
added to usual care that systematically offers outreach and shared decision-making for AUD by a social
worker. The trial sample includes 1,500 adult primary care patients who have ≥4 self-reported DSM-5 AUD
symptoms documented in their medical records. Primary outcomes are: 1) the prevalence of documented AUD
treatment engagement during 12 months of follow-up per National Committee for Quality Assurance (NCQA)
definitions (2 visits for AUD treatment in the 34 days after initiation), and 2) changes in alcohol use at follow-up
screening based on changes in the AUDIT-C score from baseline to follow-up 9-24 months later (irrespective
of treatment engagement). Intent to treat analyses include all eligible patients regardless of whether they
receive shared decision-making and compare patients in each intervention arm to those in the usual care arm.
IMPACT: Over 32 million US adults have active AUD. Many are identified in primary care but few engage in
referrals to treatment. This trial will test two practical population-based interventions to increase treatment
engagement in patients who report AUD symptoms.

Public health relevance
NARRATIVE Most patients with alcohol use disorder (AUD) do not receive treatment, including medications for AUD. The proposed pragmatic trial tests population-based primary care interventions designed to increase treatment engagement and decrease alcohol use among non-treatment seeking patients with AUD. Specifically, the trial tests two interventions to implement a patient-centered decision aid and shared decision-making in a primary care sample of 1,500 patients who have 4 or more AUD symptoms documented in their electronic health records, consistent with moderate to severe AUD.